Origins and dynamics of HIV gp120 specific B cell memory in HIV negative high-risk individuals

PROJECT SUMMARY
Decades of global effort have yet to result in a robust and effective preventative vaccine for HIV, although it has
yielded remarkable insights into the likely requirements for immunogen design and potential correlates of vaccine
mediate protection. The encouraging results of RV144 unfortunately were not reproduced in its adaptation to
South Africa with HVTN 702, however both have demonstrated that a finely tuned antibody (Ab) response to
gp120, particularly V1V2 will likely be key to an effective vaccine. Similarly, the VRC01 efficacy trial established
the defining threshold for a gp120 CD4 binding site broadly neutralizing Ab to mediate protection, and numerous
highly engineered gp120-based immunogens in clinical trials attempting to induce precise germline and B cell
receptor development pathways, demonstrate the necessity of clearly defining gp120 specific B cell memory
development. Development of a protective Ab response to HIV is likely dependent on the characteristics of the
pre-existing B cell population present prior to HIV infection or vaccination, referred to as pre-immune B cells. We
and others have demonstrated increased HIV-specific plasma Abs in individuals at high-risk for HIV acquisition
(HR) and recently we have demonstrated that HIV gp120-specific pre-immune B cells include as expected naïve
B cells, but also a substantial non-naïve proportion consisting of IgA, IgG, and IgM memory B cells. Following
HIV Env vaccination, both pre-immune B cell populations respond and undergo somatic hypermutation and
affinity maturation to give rise to high affinity HIV Env-specific Abs. Although the composition of the naïve pre-
immune HIV Env-specific repertoire is driven by germline genetics and likely to be highly similar amongst
individuals, the composition of non-naïve pre-immune HIV Env-specific repertoire is likely to be more
heterogenous. Its composition is likely driven by exposure to cross-reactive antigens such as microflora and
potentially in the instance of HR, bystander B cell activation resulting from other sexually transmitted infections,
and unproductive exposures to HIV such as with individuals with on PrEP, and subsequently more heterogenous
than the naïve pre-immune compartment. Such heterogeneity and memory bias of the pre-immune repertoire,
similar to the consequences of imprinting observed with responses to other viruses (e.g. influenza, dengue),
could result in inconsistent HIV vaccine efficacy among HR. We hypothesize that the composition and
responsiveness of the gp120 pre-immune B cell compartment is altered in HR and contributes to inconsistent
vaccine responses. To address this hypothesis, we will leverage existing longitudinal samples from US-based
HR that are or are not using PrEP and control individuals at low-risk for HIV acquisition (LR) obtained through
the NIH-funded MWCCS, a prospective Chlamydia trachomatis infection cohort, and South Africa-based HR and
LR that participated in the HVTN 702 vaccine efficacy trial to complete the following aims 1) determine the
molecular and phenotypic features of pre-immune gp120+ B cells, 2) define the mobilization of pre-immune
gp120+ B cells following vaccination, and 3) identify drivers of pre-immune gp120+ memory B cell development.

Public health relevance
PROJECT NARRATIVE An effective HIV vaccine will be dependent on stimulating a protective immune response in individuals at greatest risk for HIV infection. This project will determine the features of B cells that can respond to an HIV vaccine and how their characteristics and mobilization may differ in diverse populations of high-risk individuals. The findings will inform the development of future HIV vaccine strategies.